The Resilience of Food Security to Climate Shocks

PROJECT SUMMARY
This project will measure the vulnerability and resilience of household food security to climate shocks in
Nigeria, Ethiopia, Tanzania and Malawi. We will link longitudinal data on food security from approximately 4000
households per country, observed at 3-4 time points, to newly-available, very-high-resolution data on climate
exposures. We will then use these data to investigate household vulnerability and resilience to climate shocks
by examining both immediate and medium-term effects of climate anomalies on multiple measures of food
security across various subpopulations. This research will represent the first multi-country investigation of
vulnerability and resilience of food security to climate shocks, focusing on four countries where these concerns
are paramount.

Public health relevance
NARRATIVE Climate change is expected to have large negative consequences for the food security and health of vulnerable populations in low and middle-income countries, but to date the relationships have not been well described. We will examine the vulnerability and resilience of household food security to climate shocks using large-sample longitudinal data from Nigeria, Ethiopia, Tanzania and Malawi, four countries where these concerns are paramount.